Deciphering metabolic and cellular effectors of nutritional compensation in the circadian clock

Project Summary:
The circadian clock is used by almost every eukaryotic organism on the planet to keep time. The 24-hour
circadian period length is buffered against fluctuations in external conditions, including temperature and
nutrient levels, in a ubiquitous phenomenon called compensation. The molecular mechanisms underlying
period compensation are not well understood in any organism. The long-term goal of the laboratory is to
elucidate the mechanisms underlying compensation, in particular nutritional compensation, and the interactions
between compensation effectors and the core clock network. Work will begin in the fungal model Neurospora
crassa from which much of the current knowledge in circadian biology has derived. The regulatory architecture
of Neurospora’s core clock network is functionally homologous to animal clocks. Furthermore, Neurospora was
the first clock model with known mutations that cause defects in nutritional compensation, where period length
is no longer buffered from environmental nutrient levels. Our laboratory previously discovered that genetic
perturbation of top candidate fungal/human homologous genes caused nutrient-dependent changes in the
circadian period length, definitively establishing nutritional compensation in mammalian circadian clocks. The
overall objective of this proposal is to investigate the most significant nutritional compensation defects
identified in Neurospora for conservation with mammalian cells and for molecular mechanisms of circadian
compensation. The goals of this research are: 1) to define cellular effectors and metabolic variables that
control circadian oscillations in fungi and test for conservation in human cells, and 2) build gene regulatory
networks from time series transcriptomics across nutrients and model eukaryotic compensation. This work will
break ground into compensation mechanism, a defining feature of eukaryotic circadian clocks. It is well
established that chronic jet-lag, shift work exposure, or any condition causing prolonged desynchronization
between the human body clock and environmental light/dark cycles increase risk to develop cancer,
cardiovascular disease, or metabolic syndrome. Taken together with the modern diet and frequent evening
light exposure, it is critically important for human health and wellbeing to understand how the circadian clock is
buffered from environmental conditions.

Public health relevance
Project Narrative: This study will investigate the molecular mechanisms underlying compensation of the ~24-hour circadian clock across nutrient conditions using the fungal model Neurospora crassa and mammalian cell culture. Circadian clock network components and regulatory architecture are highly functionally conserved, and understanding nutritional compensation pathways in Neurospora should lead to understanding how the human circadian clock is buffered from different levels of external nutrients. Results from this work have the potential to improve human chronobiology, especially for individuals with sleep disorders, shift work schedules, chronic jet-lag, or circadian metabolic disease.